Using Experimental Evolution to Evaluate Environmental Effects on Microbial Mutation and Adaptation

PROJECT SUMMARY
In nature and human microbiomes, microbes regularly face challenges due to fluctuations in the availability of
resources and nutrients - a lifestyle termed feast/famine. Previous studies investigating microbial adaptation to
feast/famine have focused on the specific adaptations that allow microbes to survive extreme starvation, often
overlooking how the eventual replenishment of resources affects evolution. However, due to evolutionary
tradeoffs between growth and survival, the molecular, cellular, and behavioral phenotypes that evolve in
response to feast/famine may vary based on the duration and severity of starvation. Common adaptations to
resource limitation include expanding metabolic capability through nutritional competence and increasing
efficiency by diversification into cross-feeding ecotypes. As microbial metabolism can be constrained by many
biologically relevant factors, including the presence of oxygen, this can complicate evolution and limit potential
adaptive trajectories. Research in my lab focuses on how microbes adapt and diversify in novel complex
environments by applying multi-omic, systems microbiology approaches to experimental evolution. We plan to
investigate how oxygen availability shapes microbial evolution to feast/famine by conducting an adaptive
laboratory evolution experiment with two bacterial species, the facultative anaerobe Escherichia coli, and the
fastidious aerotolerant anaerobe Lactobacillus crispatus. We will characterize populations for fitness outcomes,
common adaptive mutations, and patterns of diversification to determine how oxygen influences adaptation to
feast/famine conditions. We will follow up by characterizing the effects of common adaptive mutations on
microbial physiology using transcriptomics and high-throughput phenotyping. Further, as oxygen can shift the
topography of the adaptive landscape by affecting the rate and spectra of mutations, we will also perform
mutation accumulation experiments on facultatively anaerobic, aerotolerant anaerobic, and obligately
anaerobic bacterial species in the presence and absence of oxygen. Studies of microbial evolution have
historically neglected fastidious microorganisms and anaerobic environments due to the challenges associated
with their culture. Our research will provide fundamental knowledge about evolutionary processes in a
neglected fraction of the microbial tree of life that accounts for a significant proportion of the human
microbiome.

Public health relevance
PROJECT NARRATIVE In order to colonize and inhabit the human microbiome, both pathogenic and commensal microbes must adapt to withstand complex stressful conditions, such as oxygen and nutrient limitation. Investigation into how the interaction of stresses influence microbial evolution is important for a deeper understanding of the infectious disease process and can lead to future targets for antimicrobial therapies and novel approaches to disease prevention.